CORE--BIOSTATISTICS

Biostatistics Core of the present Program Project Proposal serves to provide biostatistical collaboration to the investigators individually and collectively. Specifically, the Core will provide an organized system of data collection, storage, retrieval and biostatistical analysis. The Core will provide services regarding data collection, retrieval and biostatistical analysis to the Cores and the individual research components.